Methods Core

The overall purpose of the Methods Core is to address the primary specific aims of the Center by supporting research methods and promoting, developing, and sustaining collaborations focused on the study of sleep disturbance in acute and chronic conditions. The goals of the Methods Core are to: 1) provide methodological support to Center projects; 2) enhance the development of new proposals with increasing methodological sophistication; 3) create synergy among Center investigators and with other scientists in the larger research community to expand the science of sleep disturbance in chronic conditions; and 4) contribute to Center sustainability.

Public health relevance
Core support services were selected to be consistent with the programmatic aims of the Center and tailored to the specific needs of Center scientists. These services, focused on sleep disturbance and methods needed to conduct bio-behavavioral clinical trials in acute and chronic illness populations, extend, but do not duplicate, services provided by the Office of Research Support Services (ORS) of the Yale CTSA, the Clinical Epidemiological Research Center (CERC), and the YSN Office of Scholarly Affairs. (See facilities and resources). Methodological support services offered through this Core will include 1) sleep/sleep disturbance measurement; 2) patient-reported outcomes measurement; 3) quantitative clinical epidemiology and statistical methods; 4) qualitative research methods; 5) development and testing of bio-behavioral sleep disturbance management interventions; and 6) strategies to promote recruitment and retention of human subjects who have acute and chronic conditions. For each area we have designated lead investigators to coordinate services, provide expert consultation and seminars, and identify experts as needed. Senior sleep disturbance (see table 1-Admin core) and acute/chronic condition investigators (see table 2) will benefit through new interdisciplinary inter-professional collaborations and utilize consultation and other Center services.